PEDIATRIC ONCOLOGY GROUP

This proposal is a request for funding for our continued involvement in the Pediatric Oncology Group (POG). The aims and objectives are to find better means of management for malignant diseases in children and adolescents, and thus increase disease-free survival rates. The Children's Hospital of Michigan (CHM) provides diagnostic evaluation and multi-modal therapy for children throughout the State of Michigan. While there is one other Pediatric Oncology facility in the staet, the hematology/Oncology service sees almost all children and adolescents with malignant disease who live in the greater metropolitan Detroit area, and also sees large numbers of such children referred from other parts of the state (and from Canada) regardless of their ability to pay. Until 1979, the oncology service at CHM remained "independent". In September 1979, the CHM oncology team joined the pediatric division of the Southwest Oncology Group and in January 1981 joined the Pediatric Oncology Group, which appears to have even a greater potential for development of better treatment regimens for childhood malignant disease. At the time of referral and/or admission to CHM for possible malignancy, each child is seen and evaluated by the appropriate oncology team members. Following appropriate diagnostic evaluation, each child is presented and discussed at the Tumor Board, which meets weekly (or more frequently when necessary) and is attended by pediatric oncologists, pathologists, radiologists, surgeons, surgical subspecialists, and radiotherapists. A plan of action is outlined for each child's management. All such children are registered with POG, and whenever judged appropriate, children are entered on POG treatment protocols. By our participation in such a cooperative children's cancer group, our investigators are able to share new information and ideas and gain access to new multi-modal therapy regimens and investigational drugs which hopefully provide the best available care for these children. Our objectives in the coming years are: 1) to develop new protocols for children with T-AA, HIGH RISK ALL, ANLL and germ cell tumors; 2) increased participation in the POG Phase I and II drug studies including development of necessary pharmacologic studies, and 3) to continue our leukemia biology studies particularly the cytogenetic studies and oncogene studies in childhood AML.